Understanding typologies of IPV and access to services among drug-involved Black women with criminal-legal involvement who have sex with women and men

Project Summary/ Abstract:
Background: The extremely high rates of intimate partner violence (IPV) experienced by Black women in
community supervision programs (CSPs) who use drugs represents a major public health concern given the
vast overrepresentation of Black women in the criminal legal system compared to non-Hispanic white women
due to racialized drug laws and policies. National IPV surveillance data suggest that the rates of IPV in this
population may be even higher among Black bisexual women in CSPs who use drugs. However, there remains
a dearth of research that centers the experience of Black women who have sex with women and men
(WSWM). Fear of experiencing police violence and experiences of racial and sexual discrimination pose
additional challenges for Black WSMW in CSPs who use drugs to access both IPV and drug treatment
services. No studies, to date, have examined typologies of IPV and its association to accessing IPV-related
services among Black women with multiple intersecting minoritized identities including substance use, sexual
behavior, and criminal-legal involvement. To address these gaps, this application has three research aim: 1)
Identify typologies of IPV; 2) Examine how membership to latent classes are associated with accessing IPV-
related services; and 3) Explore underlying mechanisms that may link IPV class, sexual behavior, and access
to and utilization of IPV-related services. Methods: This dissertation study uses a sequential explanatory mixed
methods approach with 1) secondary baseline survey data from Project eWORTH, a NIDA-funded HIV
intervention study of 352 Black, drug-involved women mandated to CSPs and 2) primary qualitative follow-up
data with participants to inform findings from the secondary data analysis. Analysis: Latent class analysis
(LCA) will be used to identify underlying classes of IPV and association with sexual behavior (Aim 1) and
association of membership in a class with receipt of IPV-related services, controlling for sexual orientation and
gender of perpetrator with multinomial regression (Aim 2). LCA is an innovative “person-centered” approach to
measure trauma that may identify the number of underlying groups using observed characteristics. Primary
data collection and qualitative analysis (Aim 3) will enrich statistical findings from the LCA and multinomial
logistic regression analysis. The 2-year research and training program proposed in this F31 Fellowship
application will cultivate skills in mixed-methods research, essential to completing my dissertation research and
training. It will provide critical academic skills for a career as an independently funded substance abuse and
IPV prevention researcher.

Public health relevance
PROJECT NARRATIVE: Black women who use drugs and are involved in the criminal-legal system experience multiple intersecting stigmatized identities, yet research elucidating the typologies of violence experienced and its association to accessing IPV-related services is scant. The proposed F-31 Fellowship Application will examine typologies of IPV experience and its association with accessing IPV-related services among Black women who have sex with women and men (WSWM) who use drugs and are involved in the criminal-legal system in New York City. Findings from this study will inform future research into methods of improving access to and utilization of services among Black WSWM who use drugs and are involved in the criminal-legal system.